CEREBRAL METABOLIC CORRELATES OF AGGRESSIVE AND ADDICTIVE BEHAVIOR

This research is designed to determine neuroanatomical and neurochemical correlates of addictive and aggressive/impulsive behavior in human subjects. The principal focus of these studies is the measurement and correlation of regional cerebral glucose metabolic activity, using positron emission tomography (PET), cerebrospinal fluid metabolites, and measures of impulsive/aggressive behavior and excessive alcohol consumption. Past studies have correlated decreasing cerebrospinal fluid (CSF) levels of 5-hydroxy-indoleacetic acid (5-HIAA) with increasing lifetime histories of aggression. We demonstrated that decreased rCMRglu in the orbital-frontal and right temporal regions of the brain is associated with increased lifetime history of aggression. We have also shown differences in orbital-frontal glucose metabolism between men and women; similar gender-related differences in CSF 5-HIAA have been documented. During the past year we have found that male alcoholics with a history of violence have lower rCMRglu in the orbited frontal cortex than male alcoholics without a history of violence. The intent of the present project is to correlate CSF 5-HIAA levels and rCMRglu in the orbital- frontal and right temporal regions with impulsive/aggressive behavior. Subject accrual continues. We particularly need to recruit more female subjects. When a statistically significant number of research subjects have completed the study, CSF samples will be analyzed in one batch.